Applying high-reliability organization principles to home care to enhance patient safety

1 Background: Every day, older Veterans receiving VA-financed home care experience unacceptably high rates
2 of health-related adverse events (e.g., infections and injuries), many of which, if their early warning signs are
3 caught, can be prevented. Patients with both dementia and other chronic conditions are at even higher risk.
4 Home care prevents costly nursing home placement and maintains patients in their environment of choice. Yet
5 family caregivers and home care agency workers, who provide home care do not receive training to detect
6 early warning signs, because available training does not target these providers. And VA patient safety
7 initiatives using high-reliability organization (HRO) principles targets only VA-owned health care facilities. This
8 CDA-2, informed by HRO principles, will fill this gap and addresses early warning signs of adverse events in
9 home care. The CDA-2 will estimate prevalence rates of potentially avoidable hospitalization in home care;
10 assess the roles of family caregivers, home care agency workers, and VA clinical teams, in the recognition of
11 early warning signs; and adapt a solution to detect early warning signs. My background in gerontology and
12 preliminary work funded by my VISN 1 CDA partially prepare me for this work. But I need additional training in
13 non-VA data sources and advanced statistical methods for causal inference, mixed methods, care
14 coordination, and cutting-edge user-centered design to advance my career and have the CDA-2 succeed.
15 Specific Aims: My proposal fills training gaps and provides VA with rigorous, actionable research. With
16 operational partner Office of Geriatrics and Extended Care, I will achieve 3 aims with my mentors and
17 statistical experts: (1) estimate rates of potentially avoidable hospitalizations in home care and assess how
18 their prevention is related to home care and VA clinical team characteristics; (2) produce in-depth knowledge of
19 home care processes through which family caregivers, home care agency workers/supervisors, and VA
20 clinicians prevent early warning signs from escalating; and (3) adapt and pilot an existing tool to bolster the
21 detection of early warning signs in the home.
22 Methods: Aim 1: Use of Medicare (non-VA) and VA databases will enable me to estimate potentially avoidable
23 hospitalizations in my study population and assess whether their prevention is associated with types of home
24 care and VA clinical teams. Aim 2: Using mixed-methods (in-depth interviews and surveys) at 3 VAMCs
25 selected for rates estimated from Aim 1 data, I will examine multiple processes, including care coordination,
26 through which family caregivers, home care agency workers, and VA clinical team members recognize and
27 manage early warning signs. Aim 3: I will use evidence from the literature and Aim 2 findings to implement a
28 user-centered design approach to adapt and pilot an existing tool to enhance family caregivers and home care
29 agency workers’ ability to recognize early warning signs while mitigating unintended negative consequences.
30 Expected Results and Next Steps: I will provide my partners with deliverables to guide home care policy and
31 quality improvement initiatives and support family caregivers and home care agency workers and VA clinical
32 team practices to manage early warning signs. I will leverage my patient safety expertise and health equity
33 expertise will support future studies to examine VA and community resources to prevent other types of adverse
34 outcomes among home care patients (abuse/neglect) and to use a hybrid type I design to evaluate
35 effectiveness and implementation of the refined tool to recognize early warning signs.
36 Significance & Relevance to Veterans’ Health: Coming at a critical juncture in my VA research career, this
37 timely study of home care safety will help VA fulfill its promise of excellent patient safety. Home care safety is
38 in urgent need of improvement as home care expands to meet the growing needs of an aging Veteran
39 population who overwhelmingly prefers to receive long-term care at home. This CDA-2 will facilitate my growth
40 into an authority on improving healthcare delivery innovations for older Veterans with complex medical needs.

Public health relevance
1 Health-related adverse events are unacceptably high among Veterans receiving VA-funded home care, 2 particularly home care patients with both dementia and other chronic conditions. This Career Development 3 Award extends VA’s patient safety initiative into a novel care setting that serves high-risk Veterans. My 4 study will estimate potentially avoidable hospitalization rates and identify home care processes family 5 caregivers & home care agency workers use to recognize and manage early warning signs of adverse 6 events. It will also adapt, pilot, and refine a tool to help family caregivers & home care agency workers 7 recognize early warning signs. My background in gerontology and skills in VA data use and qualitative 8 methods partially prepare me for this work. My proposal fills training gaps— in non-VA data sources and 9 advanced statistical methods for causal inference, mixed methods, care coordination, and user-centered 10 design—and provides VA with rigorous, actionable research by which to improve patient safety.